Integrin regulation of vascular function in Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
This project aims at understanding the molecular mechanisms governing vascular and blood brain
barrier function in Alzheimer’s disease (AD), and their involvement in AD pathophysiology. AD research has
recently identified vascular dysfunction as a central hallmark of the disease correlating with cognitive
impairment, and actively mediating the neuroinflammatory and amyloid burden in pre-clinical models and
patients. However, the molecular mechanisms regulating vascular disfunction in AD remains limited. We found
that the integrin CD49a, highly expressed in endothelial cells and pericytes and induced by the transforming
growth factor TGF, is associated with AD (genome wide associated studies) and that modulation of CD49a
expression impact the pathophysiology of AD in a pre-clinical model. We therefore hypothesize that CD49a
expression by blood endothelial cells regulates vascular function in AD, mediates the deleterious effects of
TGFb on vascular amyloidosis and negatively contribute to AD pathophysiology and cognition.
Guided by our preliminary data, we propose to address our hypothesis using the following aims:
Aim1: Determine how CD49a regulates blood brain barrier function.
Aim2: Test the relationship between TGFb and CD49a in endothelial cells.
Aim 3: Test the contribution of endothelial CD49a in the pathophysiology of Alzheimer’s disease.
Collectively, our proposed studies will have a broad impact by: a) decipher the cell specific role of
CD49a in blood brain barrier function; b) identify CD49a has a downstream pathway for the deleterious effects
of TGFb on vascular pathology in AD; c) assert the role of CD49a and vascular dysfunction in the
pathophysiology of AD, and d) highlight the therapeutic potential of targeting CD49a in AD and other
neurovascular disorders.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease is a neurodegenerative disorder characterized by a loss of cognitive function. While research has mostly focus on the accumulation of misfolded and hyperphosphorylated proteins, new evidence suggests a strong involvement of the vasculature in Alzheimer’s disease pathophysiology. Our goal is to understand the molecular mechanisms governing vascular dysfunction in Alzheimer’s disease to restore cognitive function, and successful completion of this proposal will enhance our understanding of the vascular pathology in Alzheimer’s disease and offer new therapeutic avenues to alleviate cognitive impairment in neurodegeneration.